Unraveling the Complexities of Lp(a): From Genes to Function

Project Summary
Cardiovascular disease remains the leading cause of death and disability globally. Despite
lowering in mortality rates, residual risk of events caused by atherosclerosis are high. High
Lipoprotein(a) [Lp(a)] Levels contribute to residual risk as they increase cardiovascular risk,
despite optimal lipid lowering therapy. Lp(a) is an atherogenic, proinflammatory, and
prothrombotic lipoprotein particle. There are ethnic differences that differentiate levels, with
Blacks and Hispanics having higher Lp(a) levels when compared to Whites. These ethnic
differences are supported by the fact that Lp(a) levels are mostly genetically regulated, with
90% of its variance controlled by the LPA gene. A comprehensive map of single-base
polymorphisms (SNP) in the hypervariable LPA Kringle IV type 2 (KIV-2) copy number variation
region was published in 2019. Some of these SNP are unique to specific ethnic populations and
are linked to high and low Lp(a) levels. The latter provides a tool to interrogate the effect of SNP
on Lp(a) particle levels, particle composition and function. The current proposal utilizes a multi-
ethnic cohort at Columbia University Medical Center, where unique LPA KIV-2 variants are
identified. Using advanced lipidomic, proteomic and fluxomic technologies, we will characterize
the circulating Lp(a) particle of high frequency SNP expressed in Blacks which may be link to
their higher levels of Lp(a) compared to Hispanics and Whites. Lp(a) levels have been difficult
to alter, but newly approved and developing treatments targeting the apo(a) component of Lp(a)
lower its plasma concentrations significantly. Therefore, additional knowledge of the disease
causing “Lp(a)” particle is a need in the field as not everyone with high Lp(a) levels develops
disease.

Public health relevance
Narrative Lp(a) levels are a risk factor for Atherosclerotic Cardiovascular Disease. The levels are mostly genetically determined. The current proposal aims to understand how the genetic determinants of Lp(a) levels affect Lp(a) composition and function.